Assessing Longitudinal Changes In Peripheral Versus Central Processing of Newly Implanted Cochlear Implant Recipients

Abstract
Cochlear implants can restore a sense of hearing to recipients with severe to profound hearing loss, but speech
perception is still highly variable among recipients. After implantation, recipients take time to acclimatize to their
device and speech perception generally improves over the first six months before they reach a plateau in
performance. Unfortunately, the factors that determine the extent and timecourse of acclimatization are still not
well understood. Therefore, we will obtain longitudinal measures at multiple levels of the auditory system over
the first six months following CI activation in adults. At the periphery of the cochlear-implanted auditory system,
the electrode-neuron-interface (ENI) describes how well the implant electrodes stimulate nearby auditory nerve
cells. A poor ENI generally results in unwanted channel interaction and poorer overall performance, which may
act as a limiting factor on the extent of acclimatization. At the higher levels of auditory processing, numerous
studies have shown that cognitive factors measured before implantation are positively correlated with speech
perception scores, suggesting that central processing is involved in acclimatization, or at least in speech
perception once acclimatization has occurred. The goal of this project is to probe the origin of acclimatization
through a series of tests that start at the periphery of the auditory system and increase in complexity and inclusion
of the central auditory system. Electrically evoked compound action potentials (ECAP) can measure the
synchronous response of the auditory nerve from CI electrodes in response to stimulation of a nearby electrode.
The neural spread of excitation can be measured using ECAP and allows us to quantify channel interaction at
the periphery. Channel interaction can also be measured perceptually through psychophysical tuning curves
(PTCs), thereby passing through the ascending auditory system. Finally, the STRIPES (Spectro-Temporal
Ripple for Investigating Processor EffectivenesS) test is a different, more complex measure of spectral resolution
that does not use speech as a signal. Combined, these three measures and speech perception can better
characterize acclimatization at varying levels of complexity over the first 6 months in newly implanted recipients.
We will also determine the extent to which various cognitive factors drive or limit acclimatization when measures
of ENI quality are also taken into account. If successful, these findings could help better predict performance in
newly implanted recipients, which could then be used to guide recipient expectations or to identify recipients who
may benefit from increased aural rehabilitation or new, alternative methods of reducing channel interaction, such
as those under investigation in the Arenberg Lab.

Public health relevance
Project Narrative Cochlear implants can restore a sense of hearing to people with severe to profound hearing loss, but it usually takes six months or more for recipients to adjust and learn to use their new device to its full potential. Little is known about what drives this rate of improvement; therefore, this proposal aims to characterize the process through a series of tests that target various levels of the auditory system over the first six months of implant use in adults. A better understanding of this process will allow for better guidance of recipient expectations and for more targeted clinical and research intervention in those who are underperforming.